A natural experimental study of the impact of education on physiologic health, stress, and resilience and the role of socioemotional factors.

ABSTRACT
Education impacts health by improving access to socioeconomic resources and high-quality care (SES
mechanism) and by improving literacy and numeracy, which aids in self-care and navigating the healthcare
system (cognitive mechanism). But education does not just involve the acquisition of knowledge or cognitive
skills. Education encompasses the experiences of being in a school environment, shaped by teachers, peers,
and the “culture” of the school. Also referred to as school climate, these characteristics shape socioemotional
factors that influence resilience and one's health trajectory (resilience mechanism).
Almost all prior studies of education and health have relied on observational methods. In 2013, we began the
Reducing Inequities through Social and Educational Change Follow-up (RISE Up) Study, a natural experiment
using the admissions lottery of several high-performing public charter high schools to identify comparable
groups of adolescents “randomized” into high- and lower-performing schools. We recruited students upon high
school entrance and continue to follow this cohort currently (now age 22) with average annual retention rates
of 96%. We found the impact of schools on self-reported health and health behaviors was immediate,
substantial, and persistent beyond adolescence. By age 21, those who had attended a high-performing high
school had a 50% lower rate of alcohol use disorder, 40% reduction in reporting fair or poor physical health,
and 33% reduction in obesity/overweight. However, the improvements in physical health and obesity were only
among males. Among females, attending a high-performing schools was associated with lower rates of alcohol
use disorder, but substantially worse physical health and obesity. Surprisingly, intermediate academic
outcomes (high school graduation, grade point average, test scores, and college matriculation) did not explain
the impact of high-performing schools on substance use or physical health outcomes.
Understanding how education influences health will inform the development of future interventions and school
policies to make schools “healthier” for all students. Furthermore, our results to date are based on self-report.
Thus, we proposed to follow the RISE Up cohort from age 23-28 to better understand how schools impact
physiologic health perhaps through changes in socioemotional factors and resilience. We will measure blood
pressure and body mass index and obtain blood samples to measure glycohemoglobin and C-reactive protein.
We will examine epigenetic aging (DNA methylation), chronic stress (hair cortisol), and physiologic resilience
using the Conserved Transcriptional Response to Adversity (CTRA). CTRA is a gene expression profile
activated by fight-or-flight signaling from the sympathetic nervous system and related to greater inflammation
and lower Type I interferon innate antiviral responses. Furthermore, we will explore sex differences in the
relationship between education and physiologic health, stress, and resilience.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT Given the strong link between education and health, improving schools and educational outcomes may be a potentially effective public health intervention. In 2013, we initiated a longitudinal natural experiment to study the impact of exposure to high-performing schools on adolescent health and found significant improvements in self-reported health among males, but worse health among females. We propose to continue this cohort study and follow subjects through age 28, examining males and females in physiologic health outcomes, stress, socioemotional factors, and resilience.